Genome editing of human pancreatic islets to withstand ischemic injuries and promote immune evasion

ABSTRACT
In this proposal we apply somatic cell gene editing strategies to enhance pancreatic beta cell replacement
therapies for type 1 diabetes (T1D). We have formed a team that combines expertise in beta cell biology,
synthetic and systems biology, and islet transplant immunology to address key impediments for efficient
immunosuppression-free transplantation of pancreatic islets. We propose two orthogonal yet complementary
aims to address two critical challenges in islet transplantation - islet survival and immune rejection. Most of the
transplanted islets die before revascularization can occur, which limits the efficacy of the therapy. We have
shown hypoxia and nutrient deprivation during ischemia independently and synergistically kill transplanted islet
cells. Aim 1 of this proposal addresses the hypothesis that peri-transplant death can be alleviated by deleting
negative regulators of beta cell survival or by over-expression of positive regulators. We will take both targeted
and unbiased approaches to test candidate regulators and to identify novel regulators of human islet survival.
Our team has already performed high-throughput screens using RNAi in primary human islets using in vivo
transplant survival as a readout. We are ready to apply our expertise to CRISPRi and cDNA screens of primary
human islets. Previous clinical islet transplant experiences show that stronger immunosuppression is associated
with higher rate of insulin independence after islet transplantation. The immune system deploys multiple
redundant mechanisms to eliminate transplanted foreign tissue. This, combined with the fragility of the
transplanted islets and heightened immune functions in T1D recipients, forms a formidable immunological barrier
to beta cell replacement therapy. We hypothesize that multipronged approach of minimizing islet cell
immunogenicity, neutralizing inflammation in the graft, and blocking cellular infiltrate will shield the islets from
immune rejection without the need for systemic immunosuppression. In Aim2, we will test this hypothesis by
gene edit human islets to ablate the expression of polymorphic human leukocyte antigens. We will test dominant
strategies that block innate inflammatory cytokines TNF, IL-1 and type 1 and type 2 interferons. We will also
target adaptive immune cells by blocking their trafficking, activation and effector function. Successful
confirmation of our hypotheses will provide proof-of-principle data to support efforts of clinical translation as next
steps. We envision that these strategies may be applied to primary human islets, stem cell-derived beta cells,
and even xenogeneic islets. While these CRISPR modalities are powerful research tools for screens and proof-
of-concept experiments in the laboratory, base editing and/or prime editing may be preferred embodiments in
the clinical setting. Our end goal is to generate game-changing strategies to address these key impediments,
with a vision towards clinical translation.

Public health relevance
PROJECT NARRATIVE Islet transplantation replaces the lost insulin-producing pancreatic islet beta cells due to type 1 diabetes. However, this therapy is not widely used because of its variable efficacy and the requirement for life-long immunosuppression that can lead to a whole host of problems. We will tackle these issues using genetic engineering to help islet to withstand the stress of transplantation and resist immune attacks. The goal is to develop strategy for highly efficient islet transplantation without the need of immunosuppression.